The Southwest National Primate Research Center- Marmoset Housing Supplement 2023

Project Summary
The use of the common marmoset in biomedical research has increased by an unprecedented extent over the
past ten years and the current population size in the U.S. cannot meet the demand. The Southwest National
Primate Research Center houses one of the two NPRC marmoset colonies and is committed to its growth. In
order to support population growth and the research project needs, the SNPRC requires additional marmoset
caging.

Public health relevance
Project Narrative The populations of marmosets available for biomedical research in the U.S. are extremely limited. Only two of the NPRC’s house and breed marmosets, Wisconsin and Southwest National Primate Research Center (SNPRC). The estimated total population of marmosets in captive breeding in the U.S. is approximately 2000 animals. Several initiatives have been launched in the last several years to evaluate research demand, assess population availability and to increase the population size. Increased demand for marmosets in scientific research studies has perhaps been most acute in the areas of neuroscience and aging, where the ability to study cognition, behavior, and functional decline has often failed in translation from rodent models. Among non-human primate (NHP) models, the marmoset provides many practical advantages, including small size, ease of handling, rapid reproductive maturation, high fecundity, and social behaviors that more closely resemble those observed in humans. In order to expand the SNPRC marmoset colony it is necessary to purchase additional caging. The proposed supplement will allow SNPRC to purchase cages that will fit a minimum of 184 additional marmosets. Not only will these new cages provide the necessary space to continue to grow the colony and support research activities, it will also allow the long overdue retirement of cages that are at least 30 years old.